Impact of dilated cardio myopathy mutations on cardiac myosin structure and function

The goal of this post-baccalaureate research supplement is to enhance the impact of the parent
R01 by supporting a highly motivated recent, University of Vermont Biological Sciences graduate
for a 2-year research experience. The proposed supplement experience is designed to provide
the candidate with the resources, mentorship, and skills required to complete an independent
research project, which is a logical extension of the aims of the parent R01. The proposed
project, described in the Research Plan, has been designed to give the candidate mentored,
ﬁrst-hand experience in four phases of scientiﬁc research: 1) Rationale and experimental design;
2) reagent production and experimentation; 3) data analysis and interpretation, and; 4)
communication of results. In addition, the candidate will have the opportunity to gain expertise
in the pathogenic mechanisms of inherited cardiomyopathies, a critical area of human health,
prior to attending medical school in the Fall of 2025.

Public health relevance
The heart pumps blood into the systemic system by contracting cardiac muscle during systole, which is initiated by a rise in intracellular calcium concentration that triggers sliding of the thick and thin filaments in the muscle sarcomere. Myosin is the molecular motor that uses the energy from ATP hydrolysis to drive filament sliding and mutations in myosin can lead to dilated cardiomyopathy, a common form of heart failure that disrupts systolic contraction. This proposal will investigate the impact of dilated cardiomyopathy mutations on several aspects of human beta-cardiac myosin structure and function, including the regulatory mechanism, structural mechanism of force generation, and ability to drive filament sliding in a calcium dependent manner.